Administrative Core

ADMIN CORE 001 – VANDERBILT-INGRAM CANCER CENTER ADMINISTRATION
PROJECT SUMMARY/ABSTRACT
The mission of the Vanderbilt-Ingram Cancer Center (VICC) is to alleviate cancer death and suffering through
pioneering research; innovative patient-centered care; and evidence-based prevention, education and
community initiatives. Administration provides support services, necessary resources and an inclusive and
collegial culture that makes possible the collaborative research, patient care, community engagement, and
education and training necessary to carry out this mission. As a matrix center, VICC Administration supports
faculty, students and fellows, and staff involved with the CCSG and its ancillary activities, including those that
occupy VICC space and other research space across the institution, recipients of VICC philanthropic funds,
leaders of multi-investigator/multi-institutional grants, external affiliates and community partners, and patients
and their families. Administration plays a critical role in providing resources and expertise to support VICC
membership and key stakeholders engaged in conduct of diverse and dynamic basic, translational, clinical and
population-based research at VICC through 1) oversight of shared resources; 2) support for faculty recruitment
and retention; 3) administration and oversight of internal funding mechanisms, including CCSG developmental
funds; 4) oversight of space and facilities; 5) facilitation of interactions and communication between and among
VICC leadership and members, Vanderbilt and the community at large, through newsletters, publications,
cancer-specific or programmatic seminars, retreats and working groups; 6) organization and staffing of all
internal and external planning and evaluation efforts, Research Program Leaders, Executive Committee, Shared
Resource Oversight Group meetings; 7) oversight of VICC budgets and finance; 8) coordination and organization
of large Center grants including the CCSG progress reports and competitive renewal applications; and 9)
development, management and maintenance of data analytics reporting and visualization tools (i.e., data
warehouse and dashboards) to inform strategic decisions. Administration partners with the Community Outreach
and Engagement Office to facilitate interactions with community partners and key stakeholders and
implementation of patient and family-centered care. Additionally, Administration provides support and facilitation
of cancer-related training and career development opportunities in collaboration with Senior Leadership and the
Cancer Research Career Enhancement and Related Activities team. During the current funding period,
innovative enhancements in data analytics and visualization tools have enabled Administration to further support
Senior Leadership in implementing new research, education and training, and engagement and outreach
strategies. Additionally, these tools have enhanced support for the numerous multi-investigator and multi-
institutional awards received by VICC members, and supported new faculty recruitments and new initiatives.

Public health relevance
ADMINISTRATIVE CORE 001 – VANDERBILT-INGRAM CANCER CENTER ADMINISTRATION PROJECT NARRATIVE Per the PAR-17-095 FOA, the project narrative is not applicable for the Administrative Core.